The impact of stress and caregiver sensitivity on infant cellular aging in a population of under-resourced families: A randomized controlled trial.

Project Summary/ Abstract
The aim of the proposed randomized controlled trial (RCT) is to test if an evidence-based home visiting model
Promoting First Relationships® (PFR), that improves caregiver-sensitive and responsive care, delivered within
a primary care setting (PFR-PC), will protect young infants from the effect of stress on accelerated cellular
aging. During the first years of life, children are particularly vulnerable to adverse events, with lifelong
consequences for physical- and mental-health outcomes. These adversities are disproportionately placed on
minoritized populations and can lead to health disparities. One mechanism that has not yet received systematic
exploration in young children, in the context of an RCT, is the study of telomere length and epigenetic age
clocks, both are unique markers of cellular aging, including in pediatric samples. This RCT will focus on a
sample of minoritized and under-resourced families receiving PFR through their primary care provider. The
setting for this study is unique. We have partnered with WakeMed primary care in North Carolina, a busy
pediatric practice that utilizes an integrated care model to serve a high-need patient population. We will recruit
a low-income, community sample of 250 Spanish- and English-Speaking mothers and their infants receiving
supportive primary care from WakeMed. Mothers will be randomized to Usual Care or to PFR-in Primary Care
(PFR-PC) 10-week home visiting with follow-up PFR-PC content during well child visits. We will measure
mothers’ telomere length at baseline and child telomere length and epigenetic age clocks at baseline and one-
year post-intervention. Aim 1 will evaluate three under-studied heritability and intergenerational predictors of
cellular aging in young children, namely maternal telomere length at baseline (i.e. heritability), and maternal
Adverse Childhood Experiences, and paternal age at conception (i.e., intergenerational factors). Aim 2 will
evaluate the impact of adversity on change in cellular aging. We will test if current maternal adversity
(depression, discrimination, violence, difficult life events) predicts child cellular aging between baseline and
12-months post-intervention, controlling for heritability and intergenerational effects. Aim 3 will test whether
PFR-PC reduces accelerated cellular aging, improves parenting sensitivity and child outcomes one-year post-
intervention. Finally, an exploratory aim will evaluate PFR-PC implementation (dosage, quality,
acceptability, satisfaction, and provider fidelity). The current proposal moves the integrated care model one
step further and addresses families that need more than what is currently offered and targets prevention in an
underserved population. Early interventions are key approaches to addressing the lasting consequences of
early adversity, which represent a key public health crisis, especially when integrated into primary care settings
that are low cost, disseminatable, and grounded in strong theoretical premises related to biological pathways
through which early-life adversity is embedded within and across generations.

Public health relevance
Project Narrative Exposure to early-life adversity is a significant source of risk for poor developmental outcomes in young children, and is unequally distributed across groups, with minoritized people experiencing the greatest levels of adversity leading to gaps in mental and physical health. This proposal will test if Promoting First Relationships (PFR), an evidence-based 10-week home visiting program, delivered within a primary care setting, will operate as a protective factor against cellular aging in young children as measured by telomere length and epigenetic aging clocks. We will also evaluate the effectiveness of PFR with two additional sessions of PFR in Primary Care to enhance sensitive caregiving and parenting for low-income families in the context of primary care.